IDENTIFICATION OF HIGHLY ATTENUATED MUTANTS OF SIMIAN IMMUNODEFICIENCY VIRUS

Deletion mutants of the pathogenic clone of simian immunodeficiency virus isolate 239 (SIVmac239) were derived that are missing nef, vpr and upstream sequences (US) in the U3 region of the LTR (SIVmac239 3); nef, vpx and US (SIVmac239 3x); and nef, vpr, vpx and US (SIVmac239 4) These multiply-deleted derivatives replicated well in the continuously growing CEMx174 cell line and they were infectious for rhesus monkeys However, on the basis of virus load measurements, strength of antibody responses, and lack of disease progression, these mutants were highly attenuated Measurements of cell-associated viral load agreed well with assays of plasma viral RNA load and with the strengths of the antibody responses; thus, these measurements likely reflected the extent of viral replication in vivo A derivative of SIVmac239 lacking vif sequences (SIVmac239 vif) could be consistently grown only in a vif-complementing cell line This vif virus appeared to be very weakly i nfec tious for rhesus monkeys on the basis of sensitive antibody tests only The weak antibody responses elicited by SIVmac239 vif were apparently in response to low levels of replicating virus since they were not elicited by heat inactivated virus and the anti-SIV antibody responses persisted for greater than one year These results, and the results of previous studies, allow a rank ordering of the relative virulence of nine mutant strains of SIVmac according to the following order vpr> vpx> vpr vpx nef> 3> 3x> 4> vif> 5 The results also demonstrate that almost any desired level of attenuation can be achieved, ranging from still pathogenic in a significant proportion of animals ( vpr and vpx) to not detectably infectious ( 5), simply by varying the number and location of deletions in these five loci PUBLICATIONS Desrosiers, RC, Lifson, JD, Gibbs, JS, Czajak, SC, Howe, AYM, Arthur, LO, Johnson, RP Identification of highly attenuated mutants of simian immunodeficiency virus J Virol 1998; 72:1431-1437